Synergy of lipolysis and lipophagy in alcoholic liver disease

Project Summary/Abstract The purpose and scope of this supplement is to provide additional funds to mitigate disruptions caused by the COVID19 pandemic on research and training activities related to my parent grant (K99 AA026877). The parent grant seeks to define new mechanisms of lipid catabolism affecting alcoholic liver disease (ALD). The research activities during this period will address Specific Aim 2, which seeks to define a novel, endo-lysosome based mechanism of microlipophagy that is impacted by alcohol consumption. In addition, this supplement will allow me to complete my proposed training in the use of animal models of ALD. The results gained from the proposed research will provide a mechanistic understanding of lipid droplet catabolism in alcoholic fatty liver. Importantly, these studies will provide published research manuscripts and preliminary data in support of a future R01 proposal.

Public health relevance
Project Narrative (Public Health Relevance) Fatty liver affects ~90% of heavy drinkers. This project uses microscopy, biochemistry, mass spectrometry, and rodent models of ALD to determine the interplay between lipolysis and lipophagy in the hepatocellular breakdown of lipid droplets. The goal of this work is to gain a comprehensive understanding of hepatic lipid catabolism in order to support the development of pharmacotherapies that mitigate fatty liver progression.